SUPERHYDROPHOBIC DRUG LOADED BUTTRESSES FOR PREVENTION OF LUNGTUMOR RECURRENCE

ABSTRACT
*This proposal describes an innovative biomaterials solution to the problem of local recurrence following surgery
for non-small cell lung cancer. Despite surgery, approximately 22% of early-stage patients develop locoregional
recurrence attributed to remaining occult local residual disease. This problem results from attempts to minimize
the loss of pulmonary function by removing as little lung tissue as possible and from microscopic tumor cells
remaining near the surgical resection margin. Our solution is a buttress, which is stapled into the resection margin
during the procedure, to: 1) deliver prolonged high local concentrations of anti-cancer agents in a controlled
manner to the tissue harboring the residual cancer (and regional lymph nodes); and 2) seal the tissue to prevent
air leaks upon stapling. This novel biomaterials/surgical approach changes the paradigm by allowing the surgeon
to remove less lung tissue while treating any potential residual tumor burden effectively. We describe unique
electrospun polymeric non-woven meshes whereby the polymer composition and the bulk superhydrophobic
property (i.e., resist wetting and have high apparent contact angles) control drug release. The proposed
experiments will test the hypothesis that local delivery of established (paclitaxel & cisplatin) and new
(eupenifelden) agents via a 3-D superhydrophobic buttress, possessing controlled wettability, will afford
sustained release and cytotoxicity for greater than 60 days. We further hypothesize that a dual drug-
loaded (e.g., paclitaxel & cisplatin) buttress will reduce locoregional recurrence rates and extend survival
in a patient-derived lung cancer xenograft (PDX) surgical model, and prove to be safe and feasible for
locoregional drug delivery without adverse systemic effects or impaired local healing. Importantly,
substantial preliminary data support the proposed studies, well-characterized materials and rigorous
experimental designs are established, and essential cross-disciplinary collaborations and expertise are in place
to address the hypotheses. The specific aims of this five-year proposal are: Aim 1. Characterize the wetting
rates and the release kinetics of single and combined hydrophobic (paclitaxel or eupenifelden) and hydrophilic
(cisplatin) agents from superhydrophobic buttresses as well as the sealing capability on ex vivo lung tissue; Aim
2. Investigate efficacy and pharmacodynamic profiling of single and dual drug-loaded superhydrophobic buttress
response against resected patient-derived lung tumors in vitro; and, Aim 3. Evaluate the efficacy of drug-loaded
superhydrophobic buttresses in preventing lung cancer recurrence following resection in a patient-derived
xenograft (PDX) murine model as well as assess the safety, local tissue healing, and drug
pharmacokinetics/biodistribution after buttress implantation.

Public health relevance
Narrative *The current proposal evaluates a new superhydrophobic biomaterial as a surgically implantable buttress capable of sealing the lung tissue to prevent air leaks and delivering high dose anti-cancer agents locally to the surgical site to prevent lung tumor recurrence. Current standard of care for > 50,000 patients a year diagnosed with early stage non-small cell lung cancer is to remove the tumor via lobectomy sacrificing 20-25% of the total lung, with a resultant loss of lung function. The proposed treatment has the potential to extend survival by improved local control, similar to brachytherapy (44.7 to 70 months), but also has the potential to extend treatment to regional lymph nodes while applying a more user-friendly approach.